Improved Fetal Screening using 0.55T MRI

PROJECT SUMMARY
This project will develop a new approach for secondary fetal screening in mothers with poor acoustic windows.
Rationale: Major congenital anomalies occur in approximately 3% of all births and account for 20% of infant
deaths. In patients with good acoustic windows, most cardiac and extracardiac malformations can be
characterized by ultrasound. Fetal MRI is typically reserved for patients with central nervous system pathology,
major pulmonary malformations, or extracardiac vascular malformations; its superior soft tissue contrast and
large field of view refine the diagnosis and improve the family counseling, pregnancy management, and delivery
planning, yielding fewer neonatal complications. However, women with oligohydramnios, obesity, adverse fetal
lie, or late presentation to medical care often have poor acoustic windows that compromise the diagnostic utility
of fetal ultrasound; these women are overrepresented in underrepresented and medically underserved minority
populations. Approach: Fetal MRI represents an excellent alternative for imaging in these patients but its
expense, inconvenience, lack of availability, and safety concerns currently limit its utilization in this context. Our
hypothesis is that contemporary 0.55 Tesla wide bore MRI can provide rapid, secondary fetal screening
for high-risk pregnancies, providing greater patient comfort, safety, and access, and these benefits will
be especially strong in mothers with poor acoustic windows. Our specific aims are to: 1) assess the
potential of 0.55T to serve as a secondary fetal screening modality in women with poor acoustic windows and
diagnostically compromised ultrasound studies, 2) compare 0.55T fetal MRI image quality, diagnostic
confidence, and ease of interpretation to clinically indicated 1.5T fetal MRI, and 3) to develop new 0.55T fetal
MRI methods that leverage the advantages of this field strength. Broader Impact: This work signals a
fundamental paradigm shift in the role of fetal MRI in prenatal diagnosis by improving the speed, comfort, safety,
and diagnostic yield of fetal MRI. This project will determine if 0.55T MRI systems are suitable for siting in
Maternal Fetal Medicine clinics.

Public health relevance
PROJECT NARRATIVE This project will develop better ways for doctors to screen pregnant mothers for possible fetal problems, using magnetic resonance imaging. The new MRI will be safer and more comfortable for both mother and baby and is expected to provide better quality images than current methods.